Mass Spectrometry Identification

A variety of service and collaborative projects in protein identification have been or are being carried out within the Mass Spectrometry Research and Support Group with approximately 3000 samples analyzed from 42 scientists representing 20 principal investigators or core heads from 6 laboratory branches. One large effort is in support of the protein expression function of the Structural Biology Core Laboratory and Dr. Bob Petrovich. The Role of the MSRSG is to confirm gene expression at the protein level prior to the Structural Biology Core Laboratory handing materials over to their users. Other unpublished projects that are still ongoing include: Identification of binding partners of BAF (Archer); TTP (Blackshear); Polymerase Gamma (Copeland); Wnk1 (DeMayo); NTHL1 (Doetsch); INO80 (Hu); Grc3/Las1 (Stanley); TSEN (Stanley); SMCHD1 (Shaw); Xpr1 (Shears); GATA3 (Wade). In collaboration with the Watts laboratory, we have identified proteins from cells that have been exposed to osmotic stress. This laboratory is interested in trying to identify transcription factors involved in RNA Polymerase II pausing. Similarly, in collaboration with the Archer laboratory, we have identified proteins from donor-matched fibroblasts and induced pluripotent stem cells as a part of a larger multi-omics project evaluating how genetic ancestry influences reprograming efficiency. Additionally, a similar study evaluating the proteome changes that occur in platelets upon adrenalectomy and dexamethasone treatments is ongoing with the Cidlowski laboratory. We have also put effort into the development of lipidomics. This project involves the identification as well as the quantitation of compounds; thus, this project is included in both the identification project and the quantitation project. Additionally, the MSRSG performs protein identification to evaluate the expression and purification of various proteins from SARS-CoV-2 for several collaborators.